Muscarinic Receptor Mediation of Cocaine-Dependent Reward Signals: Impact of Pharmacological Modulation

Project Summary
Stimulant use disorder (SUD), defined as the patterned use/abuse of psychostimulants such as cocaine,
methamphetamine, or prescribed amphetamines, is an epidemic that directly affects around 2.5 million people
in the United States. Currently, there are no FDA-approved pharmacotherapies for SUD. Signaling through the
neurotransmitter dopamine (DA) in the mesolimbic circuit brain regions, the nucleus accumbens (NAc) and
ventral tegmental area (VTA), is necessary for the maintenance of SUD. Muscarinic acetylcholine receptors
(mAChRs) in the NAc have been shown to modulate the dopaminergic tone in the region and decrease
cocaine preference in rats. Of the five subtypes of mAChR, the M1 and M4 receptors show promise as
pharmacological targets for the treatment of SUD. These two receptors are located on the dendritic spines of
medium spiny neurons (MSNs) within the NAc and are fed by inputs from cholinergic interneurons (CINs).
MSNs are projection neurons containing either D1 or D2 DA receptors, which mediate the direct (reward) and
indirect (aversion) reward pathways, respectively. Previously, the modulation of mAChR activity has been
shown to reduce cocaine choice in rodents. The M1-preferring agonist xanomeline, for example, has been
shown to lower preference for cocaine in rodents. However, not only does this produce undesirable peripheral
side effects, the highly conserved orthosteric binding site makes subtype-selectivity difficult. Allosteric
modulators of mAChRs effectively solve both problems and could prove valuable for the treatment of SUD
through attenuation of cocaine-dependent increases in DA signaling in the NAc. Two mAChR PAMS, the M4-
selective VU0152100 and VU0364572, have both been shown to reduce cocaine preference in a drug versus
non-drug reinforcer assay and to reduce DA in the NAc using microdialysis. Here the following hypothesis is
proposed: Administration of mAChR-selective compounds will reduce cocaine-dependent increases in reward
signaling by modulating M1 and M4 mAChRs located on MSNs in the NAc. Aim 1 will determine the ability of
these two compounds to reduce the cocaine-dependent alterations in DA levels and dynamics in the NAc using
fiber photometry with the GRABDA fluorescent label for DA activity. Aim 2 will explore the differential role that
mAChR modulation may have on Ca2+ signaling D1- and D2-containing MSNs using fiber photometry on D1-
and D2-Cre rats.

Public health relevance
Project Narrative With no FDA-approved pharmacotherapy, stimulant use disorder (SUD) remains one of the most common drug use disorders to lack any sort of pharmacotherapy – affecting around 5 million people in the United States. Previous studies have shown that compounds, namely VU0152100 and VU0364572, that modulate the activity of the muscarinic acetylcholine receptors (mAChRs), which are notably located on the dendritic spines of medium spiny neurons in the nucleus accumbens (NAc), can reduce both cocaine preference and NAc dopamine, suggesting a decrease in cocaine-mediated reward signaling. This application provides me with the opportunity to pursue advanced training in pharmacological and neuroscientific techniques for the investigation of the neurological mechanisms behind the reduction of cocaine reward that mAChR modulation produces, which will increase the understanding of both the mAChR component of the reward pathway and the differential role that subtypes of MSNs play in SUD. Project Narrative Page XX